The Role of circ-Cdr1as in monocyte/macrophage mediated cardiac injury and repair.

ABSTRACT
Myocardial infarction is the most common form of acute cardiac injury attributing to heart failure. While there
have been significant advances in current therapies, mortality and morbidity remain high. In response to cardiac
injury, macrophages are recruited in high numbers to the infarcted myocardium and act to control the initiation,
maintenance, and resolution of the inflammatory response. Blood-derived and tissue-resident macrophages
exhibit the unique characteristic to phenotypically switch between a pro-and anti-inflammatory phenotype
producing a sequential spectrum of cytokines, chemokines, and growth factors exerting both pro-and anti-
inflammatory effects. Despite this understanding, much remains to be learned about the plasticity of
macrophages during tissue repair and the factors that regulate macrophage function. The regulatory potential of
circular RNAs (circRNA) in cardiovascular disease has begun to garner interest as a largely unexplored topic.
Circular RNAs are newly discovered non-coding RNA generated from protein-coding genes ubiquitously
expressed in mammalian tissue, highly conserved among species, and recently implicated in the possible
regulation of macrophage activation. However, there are currently no reports on the role of circRNAs in
macrophage biology and function during cardiac ischemia. Our central hypothesis is that circRNA may modulate
monocyte/macrophage biology during cardiac injury and therapeutically regulate post-injury cardiac
inflammation. Preliminary data identified circRNAs differentially expressed in pro-and anti-inflammatory
macrophages, including circRNA CDR1as (circ-CDR1as). This project aims to determine the specific role of circ-
CDR1as in the promotion of monocyte/macrophage class switching and how circ-CDR1as modulates the
functions of monocytes post-cardiac injury. Further, we plan to test the efficacy of circ-CDR1as for cardiac
repair in vivo using a mouse MI model by loss/gain of function approaches. Lastly, investigate the mechanism
by which circular circ-CDR1as invokes physiological changes in macrophages in both the steady-state and
injured heart. Collectively, our goal is to identify and establish the role of circ-CDR1as as a potential therapeutic
for the resolution of inflammation after cardiac injury to promote cardiac repair and remodeling.

Public health relevance
PROJECT NARRATIVE Cardiovascular disease is the leading cause of morbidity and mortality, characterized by persistent inflammation following cardiac injury leading to dysfunctional remodeling. This project aims to understand the role of newly discovered non-coding RNA known as circular RNAs in the regulation of monocyte/macrophage biology in cardiac injury and repair. Findings from this proposed study may potentially be crucial in understanding new mechanisms of inflammation-regulated circular RNAs as new therapeutic targets for cardiac repair and remodeling.